Modulating extracellular TCR-CD3 interactions to identify new melanoma immunotherapy targets

ABSTRACT
Melanoma is one of the deadliest and aggressive form of skin cancer. Main treatment options in metastatic
melanoma involve T cell immunotherapy using checkpoint blockade (anti-PD-1, anti-CTLA-4 and others) or
adoptive T cell therapy (ACT) with modified patient T cells. Although, durable response is only observed in a
fraction of patients. Further progress can be made by studying and targeting different T cell signaling
pathways. One such pathway is the T cell receptor (TCR) signaling pathway. T cell recognition of antigen by
the TCR and the resulting proximal signaling through the surrounding CD3 subunits are key steps in the
initiation of tumor-killing. Identification of the specific extracellular contacts between the TCR and CD3 subunits
gives precise guidance for immunotherapeutic strategies that modulate T-cell immunity by targeting signaling
through the TCR-CD3 complex. Previous studies that targeted the antigen binding site for enhancing T-cell
responses to tumor antigens often lead to off-target effects and toxicity. Based on our recent TCR-CD3
structure, we mutated specific CD3 interacting TCR-residues that resulted in different T cell cytokine
responses. Our hypothesis is that by modulating TCR-CD3 interactions in specific ways, immune-mediated
cytotoxicity to tumor antigens can be increased without losing specificity for the cancer antigen. To test our
hypothesis, in Aim 1, an in vitro retroviral TCR display method and a novel CD3-tetramer assay will be used to
mutate specific TCR-residues and identify TCRs that interact with CD3 with increased affinity, resulting in T
cells that mediate more effective functionality. In Aim 2, a structure-based TCR design will be used to identify
TCR mutants with enhanced CD3 binding ability in silico. In both instances, identified mutations will be
introduced into gp100-specific TCRs and their in vitro/in vivo tumor killing efficacy will be analyzed to validate
the anti-tumor potential of new TCRs with the goal of developing new wave of effective T cell therapies against
melanoma.

Public health relevance
NARRATIVE The T cell receptors (TCRs) present as TCR-CD3 protein complex in the T cell surface detects cancer antigens (some fragments of cancer proteins) and directs the T cell to kill the tumor through different ways. One form of immunotherapy that involves altering the TCR can help the immune system to fight against deadly cancers such as melanoma. This proposal aims at identifying and changing the critical amino acids (small molecules that constitute a protein) that are involved in CD3-interactions in the melanoma specific-TCRs which would result in increased TCR-CD3 interactions and possibly enhanced tumor-killing by the T cells.